Discovery and Biosynthesis of Bacterial Terpenoids

PROJECT SUMMARY/ABSTRACT
The long-term objectives of our research program are to (i) discover novel bacterial natural products
(NPs), (ii) elucidate the biosynthetic pathways and regulatory mechanisms of these NPs, and (iii) characterize
and utilize the discovered NPs and their biosynthetic enzymes for biomedical and biotechnological applications.
NPs are highly functionalized and evolutionarily optimized small molecules that possess unrivaled chemical
and structural diversities, resulting in a wide range of biological activities. Terpenoids, the largest and most
structurally diverse family of NPs, are considered rare in bacteria; only ~1.2% of known terpenoids are of
bacterial origin. However, genomics studies revealed that the biosynthetic enzymes responsible for terpenoid
biosynthesis are widely distributed in bacteria, particularly actinobacteria. We hypothesize that (i) bacterial
terpenoids are considerably underestimated among current NP libraries and the discovery and characterization
of novel terpenoids will lead to new drug leads and (ii) understanding the sequence-structure-function
relationships of terpenoid biosynthetic enzymes will lead to new opportunities in genome mining, combinatorial
biosynthesis, and oxidative biocatalysis. Our initial efforts follow two research directions that address
immediate needs and will set the stage for continued success in the field of terpenoid discovery and
biosynthesis. In the first direction, we will use an integrated genomics–metabolomics approach to discovery
novel bacterial terpenoids from bacteria. This will include the development of new and innovative
methodologies for targeted identification of complex bacterial terpenoids and the activation or upregulation of
terpenoid biosynthetic gene clusters. In the second direction, we will elucidate the biosynthetic pathways of
both new and known bacterial terpenoids and functionally, mechanistically, and structurally characterize
terpene synthases and their associated oxidative enzymes, particularly cytochrome P450s. We will use a
rigorous multidisciplinary approach involving genome mining, bioinformatics analysis, in vivo pathway
engineering, (un)natural product isolation and structural determination, in vitro enzymology, and protein X-ray
crystallography. Our experience in terpenoid biosynthesis and enzymology and our significant progress in
both research directions supports the feasibility of the proposed research and that we are well-suited to
establish and sustain a successful independent program in this field. In addition, we have established several
key collaborations with leaders in the fields of synthetic biology, NP drug discovery, and X-ray
crystallography that further strengthen this research program. Expected outcomes of this research program
include the revelation of the bacterial terpenome, understanding the underlying principles of how terpene
synthases dictate terpene cyclization, and the exploitation of naturally evolved oxidative enzymes to create a
toolbox of biocatalysts.

Public health relevance
PROJECT NARRATIVE Natural products are the best source of drugs and drug leads and terpenoids, the largest family of natural products, have a wide range of clinically important activities including antibiotic, anticancer, antimalarial, and immunosuppressant properties. The proposed studies will lead to the discovery of new natural products with important biological activities, facilitate future discovery efforts by the development of systems dedicated to facile identification of terpenoids in bacteria, and result in the characterization of natural product biosynthetic enzymes. A greater understanding of terpenoid biosynthesis will also provide insights into how nature constructs medicinally relevant compounds and how these enzymes may be used as tools for future discoveries in biochemistry, bioengineering, and drug development.